Recurrence of Cholera in Haiti: Exploration of Contributing Factors and Intervention Strategies

Cholera continues to be a major cause of global morbidity and mortality, with continuing spread into new areas and recurrences in areas thought to be free of cholera, driven by draught, flood, war, mass population movements, and the associated breakdown of public health infrastructure. Haiti was the site of a major cholera epidemic beginning in 2010, with over 820,000 reported cases and close to 10,000 deaths. No clinical cases from this initial epidemic were reported after February 2019, and in 2022 it was announced that cholera had been “eliminated” from Haiti. However, on September 25, 2022, cholera cases were again identified, with 64,618 suspect cholera cases and 60,171 hospitalizations subsequently reported.
We have sequenced Vibrio cholerae strains isolated from patients infected during the “new” 2022/2023 epidemic. Our genetic analysis indicates that the epidemic strain originated from an “older” Haitian V. cholerae serogroup Ogawa strain that had been circulating at sub-epidemic levels in the aquatic environment, rather than from more recent clinical serogroup Inaba isolates or from strains introduced from outside of the country. These findings raise critically important questions about the impact of strain and ecologic factors on persistence of environmental foci of V. cholerae (which are also present in the U.S. Gulf Coast environment); factors influencing occurrence of human cases and spread of epidemic disease; and best approaches to long-term cholera prevention globally.
Haiti provides an ideal setting in which to address questions related to cholera: it is on an island close to the U.S. (700 miles from Miami); with an initial epidemic caused by introduction of a single well characterized strain; and with sufficient case numbers to address critical research questions. The current study focuses on understanding factors driving re-emergence of the disease from environmental sources after three years of quiescence, including application of causal Artificial Intelligence (AI) to model/predict future epidemic waves.
Specific Aim 1: Identify strain characteristics and ecologic factors that influence evolution, virulence, and survival of V. cholerae O1 in environmental reservoirs, through environmental studies and evolutionary-informed laboratory microcosm model systems. Specific Aim 2: Monitor levels of exposure/immunity to V. cholerae O1 in communities and case cohorts to determine rates of infection in the population and monitor waning of immune responses.
Specific Aim 3: Assess phylogeographic and phylodynamic patterns driving evolution of
V. cholerae from clinical and environmental sources.
Specific Aim 4: Develop a causal AI approach to predict the occurrence of future epidemic waves and estimate effectiveness of interventions.

Public health relevance
Cholera, one of the great pandemic diseases of the ancient – and modern – world, remains a major cause of global morbidity and mortality. Vibrio cholerae is free-living in environmental reservoirs; movement of these environmental strains into human populations serves as a key driver for regional and global epidemics. The U.S. is known to have small foci of environmental V. cholerae along the Gulf Coast, which have served as the source for rare indigenous cases of cholera in this country; questions remain about factors influencing survival of these pathogens in the U.S. environment, but numbers are too small to permit appropriate studies. For the past 15 years we have studied the emergence and environmental persistence of cholera in Haiti, with the current active NIH proposal providing funding to assess the impact of environmental and host factors, including host immunity, on persistence of environmental reservoirs and emergence of epidemic disease. Data from these studies will help guide development of prevention strategies for cholera in Haiti, the Caribbean (including U.S. Gulf Coast states), and globally.